Analytical Cytometry Shared Resource

COVID-19 has impacted all countries in the world. No populations remain untouched by either direct or indirect effects. Social distancing, isolation and a variety of challenges related to employment and access to basic needs are impacting every facet of everyday life. The impact of these COVID-19 restrictions and disease must be quantified to understand and mitigate short and long term effects across the cancer continuum, especially among the most vulnerable ? underserved and minority populations and cancer patients. The goal of this study is to assess how differences in demographics (rural/urban, age, gender, race, educational attainment) will impact engagement in cancer preventive behaviors (e.g., tobacco cessation) and cancer management/survivorship behaviors (e.g., adherence to treatment, adherence to surveillance) in the context of COVID-19 environmental constraints (e.g., social distancing, employment, mental health, etc.) among adult healthy volunteers, cancer patients, and cancer survivors in Ohio, our catchment area.

Public health relevance
OVERALL NARRATIVE The Ohio State University Comprehensive Cancer Center (OSUCCC) is a matrix cancer center that integrates and leverages all of the resources of the University to achieve its broad vision of creating a cancer free world. The OSUCCC addresses the public health needs of the catchment area (the state of Ohio) through research and outreach. Research conducted within the five OSUCCC Programs focuses on ways to reduce the higher rates of lung, breast, CRC and prostate cancer as well as the higher prevalence of risky behaviors such as lack of screening, obesity, high tobacco use, and lack of HPV vaccine. Outreach efforts through the OSUCCC address the needs of underserved populations - lower education; poor; inner city African American; rural and urban Hispanic; Appalachian; rural; Amish; and Somali - by providing targeted, culturally appropriate education activities, free cancer screenings, patient navigation, community networking, environmental scans, community gardening, and addressing policy issues (eg, tobacco-free campus).